Comprehensive analysis and mitigation of the clinical effects of delineation and geometric uncertainties in conformal radiation therapy

Project Summary / Abstract
Advances in radiotherapy (RT) delivery seek to improve dose conformity to increase the therapeutic ratio. A
key step in this process is the delineation of treatment targets and normal tissue avoidance regions. As
treatment margins around delineated volumes shrink, if delineation variability is not accounted for, disparate
volumes identified by different delineators, different imaging modalities, and different structure mapping
algorithms may dominate the efficacy of both an individual patients' treatment and the collective results of
clinical trials. While efficacy should be enhanced with improved delineation consistency, improved baseline
imaging (including functional imaging) to more clearly see the tissues, and improved deformable registration
algorithms to better align delineations from different images, benefits from such improvements will be
jeopardized until methods to quantify and communicate the clinical effects of the patient-specific residual
uncertainties in these processes exist. Uncertainty quantification enables mitigation as well as determination
of when further uncertainty reductions provide no benefit. This project aims to (1) identify clinical situations in
which delineation variability negatively impacts treatment efficacy in light of other inherent treatment
uncertainties, (2) model delineation variability so that it may be estimated on a per-patient basis and
communicated to the treatment team, and (3) develop treatment planning and delivery methods that mitigate
the joint effect of delineation and other uncertainties in radiation therapy, thereby creating efficacious radiation
therapy treatment plans.

Public health relevance
Project Narrative Radiation therapy advances hinge on the ability to conform the radiation delivery to the tumor while conformably avoiding adjacent healthy tissues. Physician delineations of tumor and normal tissue regions, however, vary from physician to physician and with repeated physician delineation sessions. Similar, but smaller, variabilities exist in computer-based delineations. Other uncertainties in radiation therapy are shrinking to the point that delineation variations result in changes in tissues identified for conformal treatment and conformal avoidance. This proposal aims to identify when radiation delineation variations can negatively impact a patient's treatment, how to effectively communicate the variation and its impact to physicians, and how to design radiation treatments that are insensitive to delineation variations.